Admin Core - The State Alzheimer's Research Support Center (StARS)

Project Summary/Abstract-Administrative and Dissemination Core
Establishment of an experienced, well-integrated, and collaborative Administrative and Dissemination Core
is critical to the realization of the State Alzheimer’s Research Support Center’s (StARS’) objectives. The
Administrative and Dissemination Core features internationally recognized leaders in the field with
demonstrated experience working with diverse stakeholders across the dementia care continuum and in the
context of different types of research projects. Building on this Core leadership and expertise, we will apply a
team-science approach for overall management and operations to foster wide dissemination and use of
Center-developed tools, infrastructure, data, and findings by the broader research and stakeholder
communities. Our three specific aims are to: 1) organize, govern, and monitor all StARS activities; 2) provide
logistical, funding, and coordination support of all StARS activities; 3) establish a robust and equitable outreach
and dissemination strategy that engages underrepresented communities. We will also initiate linkages to other
NIA-funded and other national initiatives to raise awareness of Center activities. Through these efforts, the
Administrative and Dissemination Core will support the remaining Cores when completing their respective
Aims and ultimately advance the science of integrated/coordinated AD/ADRD care delivery within and across
states.